Optimization of a mHealth Physical Activity Promotion Intervention with Mindful Awareness for Adolescent and Young Adult Cancer Survivors

PROJECT SUMMARY/ABSTRACT
There are approximately 680,000 adolescent and young adult cancer survivors (AYACS) in the U.S., and the
survival rate in this group is increasing. AYACS experience a myriad of deleterious treatment-related side
effects, higher rates of physical and emotional problems and are at a heighted risk of early morbidity and
mortality compared to non-cancer age-matched controls. Increased moderate to vigorous intensity physical
activity (MVPA) is consistently associated with enhanced quality of life (QOL), reduced cancer treatment-
related side effects and chronic disease risk, and improved cancer prognosis in cancer survivors. Yet, the
majority of AYACS (~60%) do not meet cancer-specific MVPA recommendations (i.e., 150 mins/week), and
very little research on MVPA in cancers survivors has focused specifically on AYACS. Existing studies of
MVPA in survivors are largely resource-intensive, costly, and deliver multiple components (i.e., coaching calls,
supervised exercise) simultaneously limiting scalability. Three evidence-based strategies have been identified
that may be particularly useful for overcoming these barriers and increasing MVPA in AYACS: 1) electronic
delivery of a MVPA program, 2) social support, and 3) mindfulness training. However, little is known on the
unique roles of social support and mindfulness in MVPA promotion. More granular information about the
discrete effects of these components is needed to optimize intervention configuration in order to maximize an
effective and scalable MVPA program for AYACS. The purpose of this study is to apply the Multiphase
Optimization Strategy (MOST), to determine which types of social support and mindfulness training
intervention components optimally increase MVPA in a 12-week mHealth MVPA intervention with a 12 week
follow-up. MOST is a framework adapted from engineering that uses highly efficient factorial experiments to
evaluate individual, and combined, effects of intervention components to determine which ones can be
reduced, eliminated or replaced to improve efficiency. Inactive AYACS (n=304) will receive a core intervention
consisting of the OPTIMAL AYAO app and Fitbit and be randomly assigned to 4 components under
consideration for inclusion in the optimized intervention: 1) general mindfulness training; 2) MVPA specific
mindfulness training; 3) e-coach and 4) engagement of a buddy. We will also examine the effects of increasing
MVPA on symptom burden, intensities of other activities (i.e. light and sedentary), and sleep quality and
duration and potential mediators and moderators of component effects. The proposed study represents the first
systematic effort to use MOST to design an optimized, scalable mHealth MVPA intervention for AYACS. This
study will lead to an improved understanding of how to effectively change AYACS' MVPA and ultimately,
improve health and disease outcomes in this population.

Public health relevance
PROJECT NARRATIVE The public health significance of this study lies in its potential to develop an improved understanding of how to effectively change adolescent and young adult cancer survivors' (AYACS) physical activity behavior. These findings could result in more effective, scalable physical activity interventions for this population, and ultimately, improve health outcomes and reduce healthcare costs associated with cancer recurrence, comorbidities, and premature death in AYACS.